Timing live cell cycle length in diverse tissues

Timing live cell cycle length in diverse tissues
Abstract
Cellular dynamics underly tissue homeostasis and its abnormality defines many disease states. Timing
how quickly cells form tissues requires knowing the cellular generational time, or cell cycle speed, most
conveniently defined as the time interval between two consecutive mitoses. Determination of cell cycle speed
for cells in deep tissues has relied on S-phase activity to incorporate pulsed labels, or cell division mediated-
dilution of saturated labels. Thus, cell cycle rates have only been calculatable as a population average upon
fixation, or after the label has been diluted to a certain level within the detectible range, among other limitations.
An instantaneous readout of cell cycle speed in individual live cells that enable their isolation has been out of
reach. In response to the call of Catalytic Tool and Technology Development in Kidney, Urologic, and
Hematologic Diseases, I propose to develop new genetically encoded live cell cycle speed reporter. Mouse
strain expressing the new reporter will be established for detecting a wide range of cell cycle speed by
fluorescence, in situ or by flow cytometry, to catalyze the research on cellular dynamics in diverse tissues.
We will build on our recent success in developing a first-of-its-kind live cell cycle speed reporter by
exploiting the differential half-life of a color changing protein, the fluorescent timer (FT). We chose the kinetic
variant that emits blue fluorescence when newly synthesized for ~1.2 hours, before converting into a red
protein permanently during maturation. Expressed as a fusion protein to core histone H2B, cell cycle length of
individual cells can be determined by the ratio between the two fluorescence: the faster the cell cycle, the bluer
a cell appears. While this first reporter demonstrated the proof-of-principle and exceptional performance in
resolving short cell cycles, such as those of the erythroid progenitors and myeloid-committed progenitors, the
vast cell types dividing at slower rates were not resolvable. Through this proposal, we will test new design
features so that the live cell cycle speed relevant for most mammalian cell types in vivo can be conveniently
determined with a single genetically encoded reporter construct, H2B-FTmHaloD2. Given the naturally existing
wide range of cell cycle speed in the hematopoietic tissues and our own expertise in studying it, we will use the
hematopoietic stem and progenitor cells at baseline and during injury as model cell types to test, calibrate and
standardize workflows for how a new ratiometric reporter can be used to determine cellular dynamics and sort
for live cells from diverse tissues. The new design features of the H2B-FTmHaloD2 should also readily resolve
the slow cell cycles present in solid tissues such as the kidney.

Public health relevance
Timing live cell cycle length in diverse tissues Narrative An instantaneous readout of individual live cell cycle speed has been out of reach. In response to the call of Catalytic Tool and Technology Development in Kidney, Urologic, and Hematologic Diseases, I propose to develop new genetically encoded live cell cycle speed reporter. Mouse strain expressing the new reporter will be established for detecting a wide range of cell cycle speed by fluorescence, in situ or by flow cytometry, to catalyze the research on cellular dynamics in diverse tissues.